Administrative Core

Administrative Core Project Summary
The Administrative Core for this P50 includes the 1) Program Director, 2) a Biostatistician co-
investigator and his assistant who collaborate closely with the research teams from all four Projects, 3)
Subject Coordinators who assist in patient/subject scheduling for Projects 3 and 4, and 4) an External
Advisory Committee comprised of six senior scientists with highly relevant expertise, who will provide
oversight of the Center’s scientific progress and will guide the research plan when appropriate.
The purposes of this Administrative Core are to:
Aim 1: Provide leadership and administrative oversight of projects and progress
Aim 2. Foster inter-project collaboration and interactions with External Advisors
Aim 3. Manage shared resources

Public health relevance
Administrative Core Project Narrative This P50 Research Center is focused on enhancing our understanding of the prevalence, diagnosis and functional consequences of nerve damage in the inner ear. This Administrative Core is designed to oversee all the research components of the Center, foster collaboration both within and outside of the Center, manage all the budgets, and interact with research administrators at the home institution and the NIH.